Mechanistic Study of PEG-asparaginase-Induced Liver Injury

Project Summary
PEGylated asparaginase (PEG-ASNase) is one of the main drugs used for the treatment of pediatric acute
lymphoblastic leukemia (ALL). Although PEG-ASNase is safe and effective to treat pediatric ALL, its use in adults
is limited due to dose-limiting liver injury that negatively impacts therapeutic efficacy. Therefore, strategies that
can mitigate the risk of PEG-ASNase liver injury are urgently needed.
Our preliminary data show that (1) our murine model of PEG-ASNase liver injury recapitulates clinical features,
(2) PEG-ASNase activates ATGL, leading to white adipose tissue (WAT) lipolysis and hepatic lipid peroxidation
and apoptosis; (3) PEG-ASNase sensitizes hepatocytes to lipotoxicity; (4) Inhibiting adipocyte ATGL genetically
or pharmacologically protects against PEG-ASNase-induced liver injury; (5) PEG-ASNase induces eIF2α
phosphorylation in WAT and triggers adipocyte lipolysis, which can be attenuated by GCN2 inhibition; (6) PEG-
ASNase induces CTSS expression and activates ERK in WAT; (7) in vivo CTSS inhibition attenuates PEG-
ASNase-induced liver injury and ATGL activation; and (8) RNA-seq analysis identified that the PEG-ASNase-
responsive hepatocyte lipotoxicity is associated with upregulation of Cyp2e1.
Based on these observations, we hypothesize that that (1) PEG-ASNase-induced liver injury is due to ATGL
activation and subsequent WAT lipolysis. (2) Mechanistically, we postulate that PEG-ASNase-driven
WAT lipolysis is dependent on GCN2-mediated p-eIF2α and AAR activation, with CTSS induction by PEG-
ASNase leading to ATGL activation. (3) Additionally, we propose that PEG-ASNase sensitizes
hepatocytes to lipotoxicity by inducing Cyp2e1, leading to elevated ROS production and cell death. We
propose three specific aims to test our hypotheses: 1) To demonstrate that inhibition of ATGL-mediated WAT
lipolysis attenuates PEG-ASNase-induced liver injury; 2) to show that the PEG-ASNase responsive ATGL
activation and liver injury are mediated by GCN2-dependent induction of cathepsin S (CTSS); and 3) to
investigate whether the PEG-ASNase responsive induction of Cyp2e1 sensitizes hepatocytes to lipotoxicity.
The proposed work will identify a novel mechanism of drug-induced liver injury caused by the anti-leukemia drug
PEG-ASNase involving drug-induced activation of ATGL and the onset of adipose tissue lipolysis leading to
hepatic steatosis. The three aims are not interdependent but are logically related with a singular focus on
elucidating the mechanism of PEG-ASNase-induced liver injury. The long-term goal of this project is to identify
approaches leading to the safe use of PEG-ASNase and to extend the therapeutic benefit of PEG-ASNase to
adult ALL patients.

Public health relevance
Project Narrative This application describes a novel mechanism of liver injury caused by the anti-leukemia drug PEGylated asparaginase (PEG-ASNase) involving drug-induced activation of adipose triglyceride lipase (ATGL) and the onset of adipose tissue lipolysis leading to liver injury. PEG-ASNase is a crucial drug used to cure leukemias; however, its use in adult patients is largely avoided due to its high risk of liver injury, which is hallmarked by the onset of hepatic steatosis. The goals of this project are to elucidate the mechanism of PEG-ASNase-induced liver injury and to identify pharmacological strategies that can prevent PEG-ASNase-induced liver injury, increase ALL survival rates, and extend the therapeutic benefit of PEG-ASNase to adult patients.